The Genetic Basis of Human DNA Replication Timing

PROJECT SUMMARY / ABSTRACT
DNA replication follows a defined spatiotemporal program in which different parts of the genome replicate at
different times during S phase. The DNA replication timing program interfaces with genome regulation while
also influencing the genome’s stability and mutational landscape. Abnormal replication timing is associated
with genetic diseases and oncogenesis. Despite the importance of DNA replication regulation to cell and
organismal biology, we have very limited understanding of the DNA sequences and molecular mechanisms
that specify the eukaryotic DNA replication timing program. Similarly, it remains unclear how replication timing
control intersects with the regulation of gene expression and with the epigenome in general. My lab has, and
continues to, develop novel experimental and computational approaches for measuring genome-wide
replication timing. We also pioneered a unique approach of linking replication timing to human genetic variation
in order to reveal the sequence elements that control replication timing and study their mechanisms of action
(Koren et al., Cell 2014; Ding et al., Nature Communications 2021; NIH Director’s New Innovator Award DP2-
GM123495). In this MIRA application, we will: 1) generate a new dataset of human replication timing, the
largest so far, and use a computational approach to link replication timing to gene expression and epigenomic
regulation in a novel and powerful way. 2) Utilize our previous and concurrent replication timing genetic
mapping in order to experimentally edit DNA sequences controlling replication timing. This will be followed by
several epigenomic assays and genetic experiments that will reveal the mechanisms and consequences of
replication timing regulation. As part of this, we will also develop a new approach, “perturb-RT”, to
systematically screen for novel sequence elements controlling replication timing. 3) Continue our recent
success of profiling replication timing in single cells by jointly measuring replication timing and gene expression
in the same single cells. We will use this approach to study how replication timing and gene expression co-vary
during cellular differentiation. Our work will substantially contribute to the field of DNA replication timing and
beyond, by providing unprecedented genomic resources, introducing novel genetic and genomic approaches,
deciphering the genetic basis of human replication timing, and revealing new insights into replication timing
regulation and its consequences.

Public health relevance
PROJECT NARRATIVE DNA replication timing links genome regulation and stability is modulated during development, and is altered in cancer and other genetic diseases. We propose to measure replication timing in unprecedented scale across humans, identify sequence elements that control DNA replication timing, and link it to gene and epigenome regulation in novel ways. The insights obtained from this project will inform the understanding of the molecular mechanisms and functional consequences of DNA replication timing.